Pooled Optical Imaging, Neurite Tracing, and Morphometry Across Perturbations (POINT-MAP).

Project Summary
Large scale exome-wide association studies have confidently implicated over 300 genes
harboring rare mutations in the risk of neurodevelopmental disorders (NDDs), yet the specific
molecular, cellular, and functional impacts of each are mostly unknown. Our long-term goal is to
implement high-throughput functional genomics approaches to elucidate mechanisms for these
genes and their variants. Neurons extend long and elaborately branched projections and connect
to one another at synapses along these projections. A wealth of studies has implicated altered
neuronal morphology and synapses in NDDs and other complex brain disorders. The overall
objective of the proposed research is to combine a powerful human neuronal perturbation platform
with an innovative cellular barcoding strategy to develop a novel technology enabling high
throughput evaluation of the contributions of NDD risk genes on neuronal morphology and
synaptogenesis. Our central hypothesis is that many NDD risk genes converge at the
dysregulation of neuronal and synaptic function, and that we can identify such aberrations by
measuring neuronal morphology after genetically perturbing risk genes. We aim to develop a
novel scalable platform for Pooled Optical Imaging, Neurite Tracing, and Morphometry Across
Perturbations (POINT-MAP). To do so, we will develop a novel optical cellular barcode that is
linked to CRISPR perturbations, is neuronal cell-filling, and is identifiable by immunofluorescence.
We will establish an automated image-analysis pipeline for barcode retrieval, neuronal tracing,
and analysis of neuronal morphology and synaptic markers. We will demonstrate POINT-MAP in
human induced pluripotent stem cell derived neurons to simultaneously assess the functional
impact of 40 top NDD risk genes on neuronal and synaptic morphology.

Public health relevance
Project Narrative Neurodevelopmental disorders (NDDs) including intellectual disability, autism spectrum disorder (ASD), attention-deficit/hyperactivity disorder, and other conditions featuring social or cognitive deficits are among the leading causes of disability worldwide and few treatments are currently available. Recent genetic studies have identified over 300 genes harboring rare mutations in the risk of NDDs, yet the specific molecular, cellular, and functional impacts of each are mostly unknown. We propose to develop and validate a novel platform enabling high-throughput investigation of the roles of NDD risk genes in neuronal morphology and synaptic function to help transform the success of genetic discoveries into the biological insights required for eventual treatments.